Helping Guardians Navigate Youth Suicide Risk: Development and Piloting of a Brief Digital Intervention

PROJECT SUMMARY
Youth suicide is a significant global public health concern, with evidence suggesting a staggering increase over
the past decade, particularly among pre- and early adolescents. Concurrently, the widespread frequent use of
social media has reshaped the lives of youth and created substantial opportunity to harness their digital
footprints to enhance suicide risk detection on a population-wide scale. Subscription-based digital monitoring
apps have emerged with the goal of harnessing advancements in artificial intelligence to identify suicide-
related content shared or accessed, and to promptly alert parents to their child’s potential SITBs. These digital
suicide risk alerts have the potential to mitigate child SITBs by augmenting the identification of at-risk youth,
thereby facilitating prevention efforts. However, alerting parents to potential suicide risk without equipping them
with the skills necessary to respond effectively could inadvertently exacerbate youth risk. This R34 application
proposes to develop and test a digital single session intervention (SSI) for parents of pre- and early
adolescents targeting parental emotion regulation, validation, and suicide-specific monitoring. This intervention
seeks to support parents in responding effectively to digital monitoring app-generated suicide risk alerts,
thereby decreasing child SITB risk. This project aims to first develop and iteratively refine an SSI paired with a
just-in-time digital intervention (JIT) triggered by the receipt of suicide risk alerts received through a digital
monitoring app. In Phase 1, we will engage N=20 parents who use the digital monitoring app to co-create and
refine the SSI and SSI+JIT intervention prototypes. In Phase 2, we will conduct an open trial with N=15 parents
of youth (ages 10-15) screened as at-risk to inform feasibility, acceptability, and final intervention modifications.
In Phase 3, we will conduct a pilot RCT among N=99 parents of youth (ages 10-15) screened as at-risk to test
the preliminary effectiveness of the SSI and SSI+JIT interventions as compared to enhanced usual care (EUC)
on hypothesized parent-focused targets. We will assess intervention targets and outcomes via self-report
surveys from parent-child dyads at 1-, 3-, and 6-month follow-up. We hypothesize that parents in the SSI+JIT
will evidence the greatest use of targeted skills, followed by parents in the SSI-only and then EUC groups. We
also hypothesize that children of parents in the SSI+JIT and SSI-only will report less SI at follow-up compared
to children of parents in the EUC condition. Findings from this R34 proposal will inform the feasibility,
acceptability, and initial efficacy of a SSI designed to reduce child SITB risk through early parental intervention.
This work has important implications for the use of brief digital interventions to prevent suicide among at-risk
youth that may be scaled and adapted for a broad range of settings (e.g., emergency departments,
pediatrician’s offices, schools) serving parents and children.

Public health relevance
PROJECT NARRATIVE This application aims to develop and test a novel brief digital intervention for parents who receive an alert that their child may be at risk for suicide or self-harm via a subscription-based digital monitoring application. This proposal has both clinical and scientific significance because it is the first study to develop a fully automated, digital resource that will support parents in responding to their child’s suicide risk effectively. This research has the potential to improve outcomes for youth at risk for suicide by bolstering parent skills, with the goal of reducing youth suicide risk.